Leadership, Planning and Evaluation

LEADERSHIP, PLANNING AND EVALUATION
ABSTRACT
Under strong new leadership from the UCLA Jonsson Comprehensive Cancer Center (JCCC) Director, Michael
Teitell, MD, PhD (CMINT), a fresh, thorough, and prioritized JCCC strategic plan details a practical Center
mission, to accelerate discoveries that prevent and cure cancer. A new JCCC leadership team infused
enthusiasm into a Center culture that strives to eradicate cancer in LAC, the nation, and the world through
impactful research as an aspirational vision. Driving mission success is a series of exciting and achievable goals
for the next five-year project period and beyond. The JCCC 2019 – 2023 Strategic Plan maps out a new
governance structure, increased institutional support that includes participation in a pending centralized funds
distribution mechanism, research priorities, patient-centered care initiatives, and addresses all 2013 CCSG study
section comments. Significant enthusiasm emanates from increased organizational and financial commitments
by new leaders in UCLA Health Sciences and an unprecedented organizational structure that elevates the JCCC
role in fully integrating cancer research and clinical care at UCLA. This governance structure provides the
infrastructure to support innovative and impactful basic, translational, clinical, and population science research,
with strengthened community engagement to serve, and benefit from, a diverse Los Angeles County (LAC)
JCCC catchment area. Adaptability helps the JCCC achieve its ambitious mission with continuous evaluation
and planning activities, periodic evaluations by a reformulated External Advisory Board (EAB), focused ad-hoc
reviews from consultants, and frequent opportunities for input from the breadth of the JCCC membership.
Working with Teitell to drive forward Center progress is a 12-member senior leadership team, with each member
having defined areas of expertise, oversight, and responsibility. JCCC leadership, planning, and evaluation
occurs through four independent but related specific aims. Aim 1 is to plan, set, and implement JCCC scientific
goals and mission through the Strategic Plan, with ongoing evaluation of progress and corrective actions, to
maximize basic, translational, clinical, and population research, emphasizing LAC catchment area needs. Aim 2
is to enlist the JCCC EAB and ad-hoc experts to evaluate progress and identify growth opportunities that enhance
cancer research productivity, education, training, and mentoring, and community outreach and engagement
activities. Aim 3 is to guide and foster impactful JCCC collaborative and transdisciplinary research through
prioritized resource allocation. Aim 4 is to facilitate Center-wide communications amongst Senior Leaders,
Program Directors, Shared Resource Directors, members, trainees, and staff to guide the development and
growth of the JCCC. With the vision of a new Director, there is excitement to build on historic strengths of the
JCCC with a fresh focus on patient-centered integration of research, education/training, clinical care, and
community engagement in the uniquely diverse setting of LAC. With this inflection point in the Center’s strategic
trajectory, the JCCC of the near future will have added new heights to its very strong and impactful foundation.